Advancing Medical Illustration in Patient Education Materials: from Art to Science

PROJECT SUMMARY/ABSTRACT
Advancing Medical Illustration in Patient Education Materials: from Art to Science
Despite the enormous effort and expense spent in the creation of medical illustrations, there has
been no systematic empirical evaluation to date of the impact of varying illustration elements and
styles on patient comprehension of the concepts that were intended to be conveyed in the
illustration or patient anxiety induced by the illustration. In this effort we will first develop a domain
ontology that systematically describes the space of medical illustration styles in current use. We
will then use this ontology to guide the creation of a public domain corpus of patient education
documents that exhibit the most important illustration distinctions identified in the ontology, along
with knowledge tests for each. This corpus will be used to conduct an evaluation involving 8,100
individuals to assess the impact of different illustration styles on comprehension and anxiety.
Finally, we will explore the use of Embodied Conversational Agents that simulate face-to-face
conversation with a health provider, to explain patient education documents, both on 2D displays
and in immersive Virtual Reality, evaluated in a randomized study involving 300 participants.

Public health relevance
PROJECT NARRATIVE We will study different kinds of medical illustrations used in patient education materials to understand the impact these have on patient understanding and anxiety. We will also develop a conversational agent that can explain patient education documents to people, and evaluate different versions of the agent in an experiment to determine which version leads to the most learning.